From Genes to Molecules and Back: Expanding the Chemical Space of Microbial and Microbiome Natural Products

ABSTRACT
My research has aimed at accessing a previously hidden source of natural products that are encoded
in bacterial genomes, and at investigating their structures, functions, therapeutic uses, and
biosynthetic pathways. We have developed new methods to turn on production of `cryptic' natural
products and shown that low-dose antibiotics are especially effective at stimulating secondary
metabolism. We have explored the functions of secondary metabolites in microbial symbiotic
interactions, and contributed to natural product biosynthesis by uncovering over a dozen novel and
unusual metalloenzyme-catalyzed transformations, including those involved in antibiotic biogenesis.
The breadth of our work has addressed the chemistry, biology, and enzymology of microbial
secondary metabolism. My vision for the next five years is a similarly holistic approach toward
illuminating this generally understudied aspect of microbial physiology by applying it to the human
microbiome and overall expanding the chemical space of microbial natural products. Our work will be
guided by three main questions: (i) Are there cryptic metabolites in diverse genera, notably the human
microbiome and, if so, how can they be elicited? The human microbiome provides an especially intriguing
source of bacteria that can play critical roles in health and disease. Because bacteria sense and respond
to the world around them with small molecules, it is reasonable to expect that human microbiota are
sources of inducible, health-relevant natural products. (ii) Can biosynthesis-guided approaches be
leveraged to find unusual constitutive natural products in the human microbiome? Using a new
bioinformatic search protocol, we recently mapped the `universe' of ribosomal peptide natural products
synthesized by radical SAM metalloenzymes, providing an unexplored expanse of microbial biocatalysis.
The reaction scope of these enzymes will shine light on the transformations that bacteria in the
microbiome have at their disposal for concocting complex peptide natural products. (iii) Can we expand
the chemical space of natural products through a targeted search for selenium-containing metabolites?
We have recently identified the first dedicated biosynthetic pathway for incorporation of selenium into a
natural product. Genomic evidence suggests that there are many more to be discovered. Metabolite-
centric and genome-guided approaches could open the door to a collection of natural products that
contain selenium. Answering these questions will chart a new path in microbial metabolism, provide
insights into metabolites and virulence factors produced by human microbiota, and expand the chemical
space of microbial natural products.

Public health relevance
NARRATIVE Bacterial natural products are small organic molecules that are synthesized and released into the environment where they carry out a number of functions, including chemical warfare against competing organisms or communication with host cells. Recently, we have learned that only a small fraction of these natural products can be accessed by conventional methods and that the human microbiome is an especially intriguing source of small molecules that could have important impacts on health and disease. In this research proposal, we tackle both unresolved issues by applying new methods for the discovery and characterization of these hard-to-find or `cryptic' natural products, especially those in the human microbiome, and by expanding the chemical space and functional scope of microbial natural products.